The Role of Airborne PCBs in Adipogenesis, Adipose Function, and Metabolic Syndrome

PROJECT SUMMARY: PROJECT 2 – IMMUNOMETABOLIC EFFECTS OF PCBs ON ADIPOSE
Inhalation represents a main route of exposure to PCBs, particularly for children in schools and near
waterways that are contaminated with PCBs. Congeners that the ISRP has found to be at high levels in school
air accumulate in adipose tissue. Published and preliminary studies demonstrate that PCB mixtures and
individual congeners are cytotoxic and/or disrupt the function of adipocyte lineage cells and macrophages.
Epidemiologic and rodent studies provide evidence that exposure to PCBs is associated with the development
of metabolic syndrome, including disruption of glucose homeostatis, steatosis, and obesity. Western diet is
also clearly a cause of metabolic syndrome but it is unknown how PCB exposures at an early age synergize
with diet to disease. We hypothesize that exposure to PCBs found in school air impairs adipose lineage and
adipose immune cells, disrupting adipose function and exacerbating the effects of Western Diet to contribute to
metabolic syndrome. A preliminary in vivo inhalation study indicates that a 4-week early age exposure to
PCB52, a congener that is at high levels in school air, causes sex-specific changes in inflammatory and
oxidative stress pathways in adipose tissue. In aim 1, we propose to utilize unique inhalation technology to
expose mice at an early age to a school air PCB mixture, similar to what school children would be exposed to
on a regular basis, and determine how this synergizes with sex and Western Diet to cause early onset or
exacerbation of symptoms of metabolic syndrome. In aim 2, we will determine how exposure to PCBs
(mixtures, congeners, and metabolites) found in school air and the air of dredging sites disrupts adipose
function through effects on primary human adipocyte lineage cells and macrophages. Subaim 2.1 we will utilize
novel co-culture strategies that model adipose tissue to assess how PCBs affects these cells individually and
crosstalk between these cells. Subaim 2.2 will determine the mechanisms by which airborne PCBs cause
dysfunction of adipocyte lineage and immune cells, focusing on proinflammatory and oxidative stress
pathways. In both aims we will share techniques and resources with ISRP Project 1, which is studying
neurotoxic effects of PCBs. What PCB mixtures, congeners, and metabolites we use will be guided by ISRP
Projects 3 and 4, that are assessing PCBs in school air and dredging sites. Our work will rely on ISRP cores
for synthesis and analytical assessment of PCBs in samples. We will work with the community engagement
and administrative and research translation cores to disseminate information on how PCBs affect metabolic
syndrome and in research translation. The training and data management cores will provide training in
advanced analytical methods, data science and data management. Our project is relevant to SRP mandates in
that it will result in innovative technology to assess how PCBs affect adipose. Findings will be important for
assessment of risk associated with airborne PCB exposure which will be of interest to regulatory agencies and
communities subjected to PCB exposure, particularly early life exposure of children and young adults.

Public health relevance
PROJECT NARRATIVE: PROJECT 2 – IMMUNOMETABOLIC EFFECTS OF PCBs ON ADIPOSE The Iowa Superfund Research Program has shown that inhalation is a main route of exposure of children and adults to PCBs. Accumulating evidence indicates that PCB exposure is associated with the development of metabolic syndrome, which increases the risk for diabetes, cardiovascular disease, and steatosis. Project 2 will assess how diet and exposure to airborne PCBs synergize to cause metabolic syndrome, focusing on the role of adipose cells in this process, ultimately to define the risk of early-life PCB exposure in causing disease.